EDUCATION &SEMINARS &WORKSHOPS

Training, education and dissemination of information are important components of the center. This year we have conducted two successful poster sessions, one aimed for undergraduate students, and the other for R&D laboratories and Industry. Both of these are regular annual events. The center also participated in the Principal Investigator's Conference organized by the N IH.